Temporal control of cell patterning, signaling, and movement in early embryos

Regulation of gene expression along the dorsal-ventral (DV) axis of Drosophila embryos serves as a
paradigm of developmental patterning. Comparative studies of cis-regulatory elements that
support expression along the DV axis from many research groups have made it clear that
combinatorial input into enhancers by multiple transcription factors drives distinct
spatial-outputs of gene expression. A pivotal regulator of this patterning process is the
maternally-provided transcription factor Dorsal (Dl), homolog of NFKB. Dl functions as
a morphogen to activate target gene expression in a concentration-dependent manner along
the DV axis, contributing to the initiation of zygotic gene expression at the
maternal-to-zygotic transition (MZT). Using live imaging, we quantified the Dl gradient in embryos
and found, surprisingly, that levels change not only in space but also build in time. Our
focus during the previous funding period was to study the impact of these Dl dynamics on target
gene expression using quantitative approaches involving analysis of live imaging or fixed embryo
time-series data to provide insight. In the current proposal, we follow three new and exciting
directions, which relate to the timing of cell actions in early embryos and arose as a result of
the previous work. Project 1 involves studying how broadly-expressed activators and repressors
cooperate to control the onset of zygotic gene expression during the MZT. We hypothesize that
broadly-expressed repressors are equally important to pioneer activators in the control of
chromatin accessibility and thereby also regulate initiation of zygotic gene expression. Project 2
focuses on dissecting the function of short-transcripts for long genes that are expressed
specifically in the early syncytial embryo. We hypothesize that these short transcripts act to
regulate timing of cell signaling pathway activation by functioning as dominant-negative variants
of signaling molecules. Project 3 focuses on identifying the mechanism by which FGF signaling
regulates adherens junctions (AJs) and their interaction with the actin cytoskeleton to contribute
to the first epithelial-to-mesenchymal transition (EMT) in embryos; in particular, to understand
how a degron associated with one FGF ligand, Pyramus, limits signaling time. The overarching goal
of the proposed research program is to understand how the timing of these cell activities -
patterning, signaling, and movement - are controlled in developing Drosophila embryos
and to provide general insights applicable to higher animals. While many studies have focused on
spatial outputs of gene expression, less is known about the temporal dynamics of patterning.
Drosophila embryos are a tractable system to study MZT as it occurs in 3-4 hours, in
contrast to taking days in preimplantation mammalian embryos. The Drosophila embryo is
also amenable to live in vivo imaging and tracking analyses making it well-suited to the study of
nascent transcription and cell morphology. Lastly, our proposed studies will provide general
insight into early embryo development of higher animals as many regulatory mechanisms are likely
conserved.

Public health relevance
NARRATIVE The overlying goal of the research program is to understand how timing of cell activities - patterning, signaling, and movement - is regulated in the Drosophila early embryo as development proceeds. In particular, the proposed experiments will investigate how initiation of zygotic gene expression is controlled; and how this results in the activation of cell signaling, including through FGFs, which is instrumental for the support of cell movements at gastrulation to transform the blastoderm embryo into multiple layers with distinct tissue types. This work has the potential to provide insight into how diverse cellular functions are coordinated to support normal embryonic development in higher animals, as the regulatory mechanisms are likely conserved.